Prevention Center Shared Resource

PROJECT SUMMARY: PREVENTION CENTER SHARED RESOURCE
The Prevention Center Shared Resource (PCSR) aims to facilitate transdisciplinary, collaborative research
within the Fred Hutch/University of Washington/Seattle Children’s Cancer Consortium, focused on better
understanding the contributions of behavior/lifestyle modification, nutrition, physical activity, and obesity to
cancer development, prognosis, and survivorship. Centrally located at Fred Hutch, the PCSR accomplishes this
by providing Consortium investigators access to well-trained staff and a full-service research facility (over 10,000
sq ft) that contains a Research Clinic (RC), Exercise Research Center (ERC), and Human Nutrition Lab (HNL).
The RC is staffed with medical personnel who can perform clinical assessments, collect biospecimens (including
various biopsies), and obtain detailed anthropometry, including DXA-based measurements. The ERC conducts
exercise training and testing, including VO2 max, spirometry, and indirect calorimetry. Trained exercise
physiologists are available to help investigators design tailored exercise programs and to oversee exercise
sessions in-person or remotely for study participants. The HNL provides comprehensive support for the conduct
of human feeding studies as well as the food component of behavioral and community nutrition intervention
studies. Services include study diet design, food production and delivery, meal service, in-person or remotely
delivered nutritional counseling, data collection, and study participant management and monitoring according to
diet intake protocols. The highly qualified and experienced PCSR staff provide the expertise necessary to
perform interventions in physical activity, diet development and production, lifestyle counseling, and clinical
services. This allows Consortium investigators to conduct such studies without incurring the expense of hiring
and training their own staff or needing to find the appropriate physical space. The PCSR also provides training
and certification for technical staff and serves as a support resource and training facility for investigators, post-
doctoral and clinical fellows, and students interested in exercise science and nutrition research. Given the
increasing number of individuals in the US affected by cancer, it is of great importance to identify preventable
causes of cancer and ways to improve the quality of life among cancer survivors. The long-term goal of the
PCSR is to maintain itself as a unique, cutting-edge resource for the Consortium and to facilitate advances in our
knowledge of the behavioral/lifestyle, nutritional, physical activity, and obesity-related contributors to cancer
development, prognosis, and survivorship. Specifically in the next funding period, the PCSR will continue to
collaborate closely with investigators to develop cost-effective and scientifically rigorous methods by which
interventions targeting these contributors can be delivered remotely, which will allow greater access of
Consortium research to geographically distant catchment areas where greater proportions of underserved and
racial/ethnic minorities reside.